Computational Tools for Predicting and Understanding Knee Pain Spatial Patterns

Project Abstract
Osteoarthritis (OA) is the most common musculoskeletal disorder, presenting a large societal burden and
affecting over 300 million worldwide. Knee pain in patients with knee OA is a leading contributor to physical
disability and a major reason for hospital visits. Prior studies that have examined the determinants of knee
pain have not considered the complexity of knee pain reporting systematically (e.g., localized, regional or
diffuse knee pain). Moreover, the existing approaches focus on accurate prediction of knee pain and have
limitation on the interpretability. There is, therefore, a critical need to address this crucial void by developing
the computational tools with accurate prediction and interpretable properties.
The overall goal of this research is to is to build computational tools to accurately predict different incident
frequent knee pain spatial patterns and interpret the association between these knee pain patterns and the
structural abnormalities (i.e., Bone Marrow Lesions (BML)) detected on Magnetic Resonance Imaging (MRI).
The central hypothesis is that early in the disease course, abnormalities of structural features on knee MRI
will be determinants of specific knee pain spatial patterns.
This study is innovative in that it focuses on incident knee pain, examining knee pain spatial patterns early in
the disease course, and taking into account different definitions of knee pain. This study is also innovative in
that the study team will leverage excellent prediction performance of deep learning and interpretable
properties of statistical approaches to predict and understand different knee pain spatial patterns.
The specific aims are 1) To adapt a Transformer-based deep learning approach for predicting the incident
localized, regional, or diffuse knee pain from MRIs in the Osteoarthritis Initiative (OAI), and 2) to develop a
novel interpretable statistical framework for characterizing the relationship between BMLs on MRIs and
incident localized, regional, or diffuse knee pain.

Public health relevance
Project Narrative By implementing the developed approaches, the research team aims to attain increased accuracy in identifying knees with a high risk of incident frequent knee pain in specific locations, along with the MRI-defined determinants associated with these knee pain patterns. It is expected that the proposed studies will provide timely information that can help identify patients who would be most likely to benefit from pharmacologic and non-pharmacologic interventions to prevent or slow the progression of knee osteoarthritis in clinical trials. The objectives of this proposal can thus potentially reduce the public health impact of knee osteoarthritis.